Bayesian approaches to identify persons with osteoarthritis in electronic health records and administrative health data in the absence of a perfect reference standard

PROJECT SUMMARY/ABSTRACT
Osteoarthritis (OA) is a leading contributor to the Global Burden of Disease Study’s Years Lived with Disability
(YLDs) measure, and due to aging and increasing rates of obesity, its ranking is steadily rising. With no
treatments that delay progression of OA available, the cost of joint replacements is straining Medicare budgets
and contributing to enormous economic impact and public health burdens. We are in critical need of a better
understanding of factors that prevent or delay worsening OA and of its population impact. Electronic health
records (EHR) and administrative health data are a major resource for data-driven approaches in real-world
evidence studies and are increasingly used to study disease risk factors and treatments and the genetics of
disease such as those from the UK Biobank, where these databases are used to identify cases of disease that
tied to genetic susceptibilities. With data on millions of patients, these databases also allow inquiries into health
care utilization and costs, inequities of care, growing prevalence of OA and its burden, treatments, adherence
of care to guidelines and attendant comorbidities. The validity of research using administrative data; however,
relies on accurate characterization and identification of disease cases. The long-term goal of this research is to
improve OA case ascertainment in EHR and administrative health data. The central hypothesis of this proposal
is that by using multiple data elements including imperfect diagnosis and procedures codes and understanding
the conditional dependence among the data elements, the accuracy and predictive values of OA case finding
algorithms can be substantially improved. Using insurance claims data from one of the largest administrative
health databases in the US, MarketScan, and EHR data from Boston Medical Center, this proposal aims (1) to
develop an algorithm in a large administrative database to estimate the probability of OA in an individual
accounting for the conditional dependence of its multiple diagnosis and procedure codes; (2) in an EHR
database, to compare our approach with conventional diagnosis/procedure code-based algorithms validated
against chart review. The contribution of this work is significant because it is the first OA algorithm to exploit
the conditional dependencies between its data elements to improve accuracy. Further, the proposed
methodology is significant in that it can be broadly applied to other conditions and diseases that can
substantially improve the quality of real-world evidence observational studies using administrative health data.

Public health relevance
PROJECT NARRATIVE Accurate characterization of osteoarthritis, the most prevalent form of arthritis and a leading cause of disability, in administrative health data is needed to study its public health burden, economic impact, cost of care, inequities in care, and adherence of care to guidelines and attendant comorbidities. Case finding algorithms for osteoarthritis had limited success, often missing more than half of cases, mainly due to widespread underreporting of osteoarthritis diagnostic labels and the fact that guidelines discourage acquisition of imaging that provides a definitive diagnosis. This proposal introduces novel Bayesian approaches to accurately identify persons with osteoarthritis using multiple data elements from electronic health records and administrative health data that can bring new insights into osteoarthritis research by facilitating observational and data-driven studies of disease risk factors and treatments that ultimately will benefit millions of Americans affected by osteoarthritis.